IPREP: IUPUI Graduate Preparation for the Biomedical and Behavioral Sciences.

IPREP Project Summary
The IUPUI Postbaccalaureate Research Education Program (IPREP) will provide academic enhancement and extensive
research experiences to prepare talented college graduates from diverse backgrounds for success in rigorous Ph.D. and
M.D./Ph.D. programs in the biomedical and behavioral sciences. Six students will be recruited annually from historically
black colleges and universities, predominantly Hispanic serving institutions and tribal colleges as well as from a pool of
high performing underrepresented minority students from existing IUPUI programs. IPREP Fellows will begin the pro-
gram on June 1st each year with a one-week orientation where their skills and needs will be assessed, and from which a
detailed personal development plan will be established. Weeks 2-7 will be two-week rotations in three labs chosen by the
Fellows. Every IPREP Fellow will then be paired with an experienced research mentor with active sponsored research,
who will incorporate the student as a paid employee into their research enterprise. IPREP Fellows will receive additional
ongoing support from the IUPUI Center for Research and Learning that will include individualized advising, assistance in
preparing graduate school applications, planning for graduate school visits and interviews, as well as monthly monitoring
and reporting of progress to the Program Director. IPREP Fellows will leave the program with enhanced laboratory and
research sills, including improved abilities to ask and solve research questions (critical thinking), increased understanding
of expectations of graduate programs, awareness of process for seeking external funding for graduate education, improved
self-confidence and ability to succeed in a competitive academic environment. At least five of the six IPREP Fellows will
be successful in obtaining admission to rigorous Ph.D. and Ph.D./M.D. programs and will successfully complete their
graduate/professional programs.

Public health relevance
Project Narrative The long-term goal of the IUPUI Postbaccalaureate Research Education Program (IPREP) is to improve diversity in the community of graduate students and faculty for five targeted Ph.D. programs in the STEM area at IUPUI. Training will be available for 6 students each year in areas of interest to the national health including basic medical sciences, clinical psychology, addictions neuroscience, human performance, and medical neuro-science toward the goal of matriculation into these graduate programs, or similar graduate programs at other universities. This will be accomplished both through laboratory research and through professional and career development activities.